INTERNAT CONF ON ETHICS, HEALTH POLICY &EPIDEMIOLOGY

This is a request for funds to partially support an international conference on issues of ethics and health policy that arise in epidemiological practice and research. Some of these problems particularly relating to privacy, informed consent of subjects, and access to information sources have been described and discussed since the 1960s, but additional problems related to influence of sources of support on presentation of the results of studies, as well as critical review of methodologic issues, have also been recognized more recently. The International Epidemiological Association (IEA) has requested the development of a set of guidelines. This conference will provide an opportunity for broad, open discussion of the various proposed guidelines which are being put forward. The two-and-a-half days just prior to the Los Angeles International Scientific Meeting of the IEA on August 5-9, 1990, will be an ideal opportunity to facilitate broad international participation in these discussions. Funds are requested for one planning meeting, transportation, and subsistence for invited speakers and discussion leaders, and for publication of the proceedings.